Administrative Core

PROJECT SUMMARY: Administrative Core
The Administrative Core provides centralized executive and scientific leadership to facilitate the overarching
goals of the Administrative Core of the Texas Medical Center Digestive Disease Center (DDC) to support the
continuing development of the DDC Research Base and ensure responsiveness of the Research Cores to the
needs of DDC members among the three participating institutions located in Houston’s TMC: Baylor College
of Medicine [BCM], The University of Texas Health Science Center [UTHSC] and UT MD Anderson Cancer
Center [MDACC]. The DDC is the only NIH funded DDRCC in the southcentral region of the U.S. The
administrative and scientific leadership of the DDC is provided by the Executive Committee consisting of DDC
Director, Hashem B. El-Serag, MD, MPH [BCM], Co-Director, Jason Mills, MD, PhD [BCM], an Associate
Director, James Versalovic, MD, PhD, and the two Assistant Directors representing UTHSC and MDACC: J.
Marc Rhoads MD [UTHSC] and Dr. Robert Bresalier MD [MDACC]. Dr. Mills is an innovative addition to the
leadership team, bringing over a decade’s experience of leadership for the Washington University DDRCC.
The Executive Committee is augmented by the Internal Advisory Committee and External Advisory Committee,
composed of renowned internal and external investigators, respectively. A clear succession plan is identified
and approved by both committees. The Executive Committee meets quarterly and on an ad hoc basis as
warranted. The Internal Advisory Committee meets monthly and comprises the Director, Co-Director,
Associate Director, Assistant Directors, Core Directors, Clinical Liaisons, and Pilot Feasibility and Enrichment
Program Leaders. One DDC senior administrator provides the necessary support for day-to-day financial
management and operations of the DDC. BCM, UTH and MDACC provide exceptional institutional support
and infrastructure to promote the continued growth of our center.
The Administrative Core plans and implements a dynamic multimodal six-element DDC Enrichment Program
that includes Research Seminars, and annual DDC Research Symposium. The Administrative Core oversees
the Pilot and Feasibility Program. The Administrative Core oversees the DDC Research Core activity, services
and chargebacks using an online platform iLab Solutions system across Cores Conduct, and conducts an
annual online (via Survey Monkey) member survey to assess evolving member needs. The Core also oversees
the DDC’s communications with internal and external stakeholders. Major operational accomplishments of the
Administrative Core have been to implement a fully functional web-based pilot feasibility application and
scoring system in addition to a virtual symposium platform which supports remote presentations, virtual
breakout sessions, networking opportunities, and a simulated poster competition. These new systems have
increased productivity and participation in DDC enrichment activities. Over 26 publications have cited the
support of the DDC Administrative Core in the current funding cycle.

Public health relevance
PROJECT NARRATIVE: Administrative Core Per instructions in RFA-DK-21-026, we have not included a project narrative in this application. As specified, we have included the narrative in the overall component.